Task B08: Development and Use of a Non-Human Primate Model of SARS-CoV-2 Infection

This contract provides for the development and standardization of non-human primate models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.